Transitioning GLYCAM-Web to a self-sustaining carbohydrate modeling service

Project Summary
For over a decade, GLYCAM-Web (www.glycam.org) has provided the scientific community with a suite of
online tools for simplifying the modeling of 3D structures of carbohydrates, glycoproteins, and their interactions
with proteins. The highly plastic nature of oligosaccharides and the fact that they are typically branched means
that they place unique demands on both software developers and users. This is exacerbated by their complex
and archaic nomenclature. GLYCAM-web was developed by a team of people with a unique depth of
expertise in carbohydrate chemistry and informatics, with the overarching goal of making carbohydrate
modeling more accessible to scientists who either lack computational expertise, or whose familiarity with
carbohydrates is limited.
According to AWstats and in-house code GLYCAM-Web was visited by ~110,000 unique addresses and had
~11,000 PDB file downloads from 2016 to 2019. The downloads are usually associated with creating and
viewing 3D structures of glycans and for offline modeling. We have included a detailed usage analysis in the
Research Strategy to emphasize the significance of this resource to the NIGMS research community.
The development of GLYCAM-Web has been primarily supported through an NIH NIGMS P41 grant held at the
Complex Carbohydrate Research Center at the University of Georgia that has been continuously renewed
since the 1990s. With the ending of the P41 program, we are not eligible for further support within the P41
program, and are seeking support that with enable us to transition GLYCAM-Web to a near self-sustaining
resource whose operation costs are offset by new fee-for-service functionality targeting users who wish to
perform molecular dynamics simulations, but who lack the expertise or infrastructure to do so. The decade-
long development of GLYCAM-Web has seen the infrastructure grow and change with the advent of new
architectures, code evolution, and increased security requirements, leading to a complex code base involving
the C++, JAVA, and PYTHON languages. Thus a significant aspect of this proposal involves code refactoring
to unify the code base, which will directly reduce maintenance costs. To achieve near self-sustainability, we
have developed the four aims what will address the necessary improvements to code and infrastructure:
usability, transferability, maintainability, and sustainability.

Public health relevance
Project Narrative For over a decade, the suite of webtools at GLYCAM-Web (glycam.org) has provided free and easy-to-use carbohydrate 3D modeling services for the scientific community (110,000 visits from unique addresses from 2016 to 2019). This grant outlines our plans to improve usability, transferability, maintainability and sustainability of the website. Successful completion of the aims of this grant will transition GLYCAM-Web into an efficient, near self-sustaining site and ensure the long-term viability of GLYCAM-Web beyond the lifespan of the Woods Group or the P41 support program.